4/6 Planning for the HEALthy Early Development Study

ABSTRACT The Planning for the HEALthy Early Development Study will contribute to the design and recommended protocol for a future large-scale, multi-site research study to prospectively examine human brain, cognitive, behavioral, social and emotional development of children beginning prenatally through ages 9-10, and to determine the impact of maternal pre- and postnatal substance use on short- and long-term development of children. The Planning Study will link investigators across 6 research sites who have complementary experience and expertise in the areas that are essential to designing the study. Planning activities will be accomplished using a coordinated set of 10 Working Groups who will work collaboratively to design a sampling and recruitment strategy for a future large-scale study, to identify and recommend strategies for addressing the challenges to ethical recruitment and retention of vulnerable populations, and to develop and test a common protocol for neuroimaging, infant and child assessments, exposure assessment, biospecimen collection, and integration of novel technologies. By the end of the Planning Phase, the 6 Consortium sites will have produced and tested a recommended protocol for the future multi-site study, and will have established feasibility of carrying out the study protocol at each of the 6 linked sites.

Public health relevance
Project Narrative – Supplement There is a dearth of information on the effects of maternal COVID-19 infection during pregnancy, including limited data regarding the effect on behaviors, access to and uptake of medical care, and pregnancy outcomes for all pregnant women functioning in everyday life under pandemic conditions. Within the existing infrastructure of the U.S and Canada-wide MotherToBaby pregnancy cohort studies, we will evaluate COVID-19 symptoms, testing and antibody status as well as the behaviors of pregnant study participants in the presence of the pandemic. Findings will be informative for a future Phase II study of the normal and abnormal development of children exposed to a wide-ranging set of prenatal stressors.